Non-Animal Test Method To Determine The Ocular Safety Of Consumer Products and Chemicals

? DESCRIPTION (provided by applicant): OptiSafeTM is a standardized and pre-validated non-animal test method that can be used to predict the ocular irritation potential of products and chemicals. Three unique variables are used to make an ocular irritation prediction: damage to water soluble molecules, damage to water insoluble molecules and buffering capacity. The goal of the proposed research is to validate the OptiSafeTM UMA method. There is currently a commercial and regulatory need for an accurate test to determine the ocular irritancy potential of cosmetics without harming animals.

Public health relevance
PUBLIC HEALTH RELEVANCE: OptiSafeTM is a non-animal test method that can be used to determine if a product or substance has potential to damage the eye. The test method has undergone pre-validation and a kit has been made. The aim of the proposed SBIR phase I project is determine if outside labs can conduct the assay and further validate the test method.